Cloud/Web-Based Platform for Quantitative SPECT Reconstruction of Therapeutic Radionuclides

Summary
Radiopharmaceutical therapy (RPT) is an emerging cancer treatment that delivers radiation directly to cancer
cells. The commercial success of 223Ra (Xofigotm) for resistant metastatic prostate cancer, Lutathera for
neuroendocrine tumors, and approval of Pluvicto for prostate cancer provides an example of the therapeutic and
commercial potential of this modality. In addition, drug companies have large libraries of targets and targeting
molecules. Progress in chelators and commercial availability of alpha emitters such as 212Pb, 227Th, and 225Ac and
the large number of clinical trials of RPTs and companies involved in RPT development are indicators that RPT
is poised to become an important tool for cancer therapy. Multiple companies and academic centers are
developing drugs based on alpha emitters. For example, Bayer has presented data on Th-227-based agents
targeting CD22, HER2, PSMA and FGFR2 receptors, and Rayzebio on Ac-225-DOTATE. FDA approval of RPT
agents requires tumor and normal tissue dose estimates. European regulations mandate personalized
dosimetry. Optimal use of RPTs requires a precision medicine approach based on quantitative imaging and
dosimetry. The foundation of reliable dosimetry is quantitative imaging. Commercial quantitative SPECT/CT
software packages are not aimed at therapeutic radionuclides and especially not alpha emitters: their
reconstruction methods are too simple to support accurate quantitative reconstructions of these radionuclides.
Quantitative SPECT of two simultaneously present radionuclides is not available and would be provided in this
work. The overall goal of this project is to develop a prototype web/cloud-based quantitative SPECT
reconstruction software system that can be used for clinical trials and ultimately for clinical RPT dosimetry. The
ability to directly image Ra-223, Th-227/Ra-223, Pb-212, and Ac-225 (via Fr-221)/Bi-213 has the potential to
expedite trials by eliminating the time and expense needed to develop surrogates, to help better select patients
likely to respond, and to tailor doses to maximize efficacy while reducing toxicity. To develop this system, we
propose to (1) improve existing quantitate methods by improving scatter and downscatter modeling and adding
rigorous partial volume compensation; (2) perform experiments needed to select appropriate energy windows
and collimators for quantitative imaging of these radionuclides (3) develop practical calibration methods that can
be translated to clinical sites (4) validate and characterize the methods developed above so they can be applied
appropriately and there is an understanding of their limits and uncertainties; and (5) in parallel, integrate
quantitative SPECT into Rapid’s web/cloud-based dosimetry platform. Successful completion of this would
provide a platform for quantitative SPECT of radionuclides used in alpha emitter therapy that are well
characterized and validated and could be immediately used in clinical trials and serve as the basis for a product
designed for clinical dosimetry.

Public health relevance
Project Narrative Regulatory approval and optimal use of radiopharmaceutical cancer therapies require personalized dosimetry, which is based on quantitative imaging of the distribution of the therapeutic radionuclide. These radionuclides, especially alpha emitters, are difficult to image due to their complex emission spectrum, and quantitative reconstruction methods for them are not commercially available. This project seeks to deliver a web/cloud-based commercial-grade software package for performing quantitative SPECT reconstruction for difficult-to-image radionuclides to drug developers of RPTs and clinical users.